SGLT-inhibitors in patients with hypertrophic cardiomyopathy

Project summary
Patients with hypertrophic cardiomyopathy (HCM) experience a progressive disease course and bear a
substantial symptomatic burden, marked by heart failure, atrial and ventricular arrhythmias and early mortality.
Patients with symptomatic HCM, but without obstruction of the left ventricular outflow tract (so-called non-
obstructive HCM), are a particular challenge to manage, as no treatments have proven effective at improving
symptoms or impacting the trajectory of disease progression. This proposal will focus on sodium-glucose
cotransporter 2 inhibitors (SGLT2i) as a potential therapeutic option for non-obstructive HCM. Initially
developed as hypoglycemic drugs to treat type-2 diabetes mellitus (T2DM), SGLT2i unexpectedly conferred a
remarkable cardioprotective benefit with robust reductions in cardiovascular mortality and hospitalizations for
heart failure, irrespective of diabetic status or ejection fraction. While the mechanisms of action by which
SGLT2i are exerting such beneficial cardiovascular effects are still unclear, an improvement in cardiac
energetics has been proposed as one plausible mechanism based on evidence for increased cardiac ketone
oxidation and ATP content in preclinical models of heart failure. The overall goal of this study is to determine
the safety, feasibility, and preliminary efficacy of SGLT2i in patients with non-obstructive HCM. The rationale
for conducting this study is based on the similarities between non-obstructive HCM and heart failure with
preserved ejection fraction, and also the unique structural and functional features of HCM that make an early
phase trial essential before implementation of larger phase clinical trials or adoption of “off label” use. We will
perform a randomized, double-blind, cross-over study of the SGLT2i dapagliflozin vs placebo in 26 patients
with non-obstructive HCM and ejection fraction >50%. Our primary safety outcomes will be rhythm monitoring
and intracavitary left ventricular gradients assessed by echocardiography. Our preliminary efficacy endpoints
will be change in peak oxygen consumption (VO2), left ventricular systolic and diastolic function by
echocardiography, NT-proBNP, ambulatory actigraphy, and quality of life assessment. In an exploratory aim,
we will test whether SGLT2i improve cardiac energetics in HCM using 31P-MR spectroscopy to quantify
relative amounts of myocardial energy stores, specifically phosphocreatine and ATP. This early phase study
seeks to extend the marked cardiovascular benefits of SGLT2i recently demonstrated for heart failure with
reduced and preserved ejection fraction, to patients with HCM. The study team includes investigators with a
strong track record in early phase clinical trials in HCM, at a high volume HCM center at the University of
Pennsylvania, in collaboration with experienced clinician investigators in endocrinology and radiology at the
Children's Hospital of Pennsylvania. The results of this study will provide essential preliminary data to
determine if larger scale clinical trials of SGLT2i in HCM should be pursued, and explore a shift in metabolic
substrate utilization as a potential mechanism of action of conferred benefit.

Public health relevance
Project narrative Patients with hypertrophic cardiomyopathy suffer from heart failure, abnormal heart rhythms, and shortened life spans. There are few current treatments that improve symptoms or change the trajectory of disease progression in these patients. This proposal will test the potential risks and benefits of a class of drugs called sodium-glucose cotransporter 2 inhibitors, proven effective for treatment of diabetes and other forms of heart failure, in patients with hypertrophic cardiomyopathy.